Tissue elasticity and viscosity modulates macrophage-fibroblast signaling in cardiac fibrosis

Project Summary/Abstract
Cardiac fibrosis remains a global health problem that results from highly coordinated interactions between
macrophages, versatile cells of the innate immune system, and fibroblasts, cells responsible for extracellular
matrix production. Initial stages of fibrosis are characterized by an acute inflammatory response that spans a
period of hours-days and is followed by a healing phase which lasts days-weeks. This creates a complex
microenvironment consisting of biochemical stimuli that modulates cell function resulting in the replacement of
native tissue with a more elastic and less viscous scar tissue. However, while the effects of biochemical cues
have been studied, traditional co-culture methods lack spatial and temporal control to mimic the in vivo
environment. For example, static culture methods, including conditioned media transfers and direct co-cultures,
are unable fully recapitulate the close proximity of cell-cell signaling and the dynamic switch from inflammatory
to healing responses in macrophage activation state to study biochemical and physical cell-cell interactions. In
addition to biochemical cues, the altered mechanical environment also exposes cells to biophysical stimuli,
including tissue elasticity and viscosity, that have been shown to regulate macrophage and fibroblast function
independently, but the effects of mechanical stimuli in modulating macrophage-fibroblast interactions are
unknown. Moreover, Marfan syndrome, an autosomal dominant inherited disorder characterized by mutations to
the fibrillin-1 gene, results in enhanced cellular oxidative stresses which promote pro-fibrotic cell function and
alter cardiovascular tissue mechanics. However, the resulting effects on macrophages and fibroblasts as well as
the role of a changing mechanical landscape in pathology are unknown. Preliminary work identified the
importance of macrophage-fibroblast signaling in promoting fibrotic responses. However, several key questions
remain. In this study, I hypothesize that a fibrotic environment, characterized by enhanced elasticity and
reduced viscosity, promotes macrophage pro-fibrotic signaling to cardiac fibroblasts which, in turn,
exacerbates cardiac fibrosis. To evaluate this hypothesis, I will develop and utilize a modular engineered cell
culture system to investigate the effects of elasticity and viscosity in macrophage and fibroblast function
independently and in dynamic cell-cell interactions to promote pro-fibrotic signaling (Aim 1). Additionally, I will
elucidate the role of elasticity and viscosity in regulating oxidative stresses to promote pro-fibrotic macrophage-
fibroblast signaling in Marfan Syndrome (Aim 2). The completion of these aims will not only provide a better
understanding of material mechanics within cardiovascular disease but may also uncover molecular targets
which can directly influence macrophage-fibroblast signaling and the progression of cardiovascular fibrosis.

Public health relevance
Project Narrative This proposal seeks to develop and utilize an engineered cell culture system with greater spatial and temporal control of cell-cell interactions to understand the effects of tissue stiffness and viscosity in modulating macrophage-fibroblast signaling in cardiac fibrosis. Using this cell culture system, we hope to uncover mechanotransduction specific mechanisms in healthy as well as Marfan Syndrome associated cells. These fundamental studies will provide greater insight into the role of tissue mechanics in regulating cell-cell communication as well as uncover pathways and potential molecular targets involved in cardiac fibrosis.